Genome Editing and Animal Models Shared Resource

PROJECT SUMMARY / ABSTRACT
Genetically engineered mice and rats are widely used as models for defining the molecular mechanisms
underlying cancer etiology and for evaluating new strategies for cancer treatment and prevention. The Genome
Editing and Animal Models Shared Resource (GEAM), formerly the Transgenic and Mutant Animal Facility, has
served as a shared resource for the University of Wisconsin Carbone Cancer Center (UWCCC) for over two
decades and is one of the elite facilities within the United States in offering a comprehensive array of services
related to generation and preservation of genome-edited animal models. The primary mission of the GEAM is
to make state-of-the-art genome editing technologies accessible to UWCCC members. Specific Aim 1 is to
provide the expertise and infrastructure required to generate novel and relevant genome-edited or transgenic
animal models and genome-edited cell models for use in cancer research. GEAM staff are capable of serving
UWCCC members in all aspects of experiment planning and execution, including design of efficient and
specific approaches to achieve the desired loss, gain, or alteration of gene function using CRISPR/Cas9 or
other genome editing and transgene-based approaches; design, production and use of the required genome
editing reagents or transgene vectors; identification of animals that carry the desired genome edit or transgene;
and minimization of off target edits. Our skills in reproductive biology, embryo manipulation, and animal
husbandry enable us to edit the genomes of inbred mouse and rat strains that exhibit low reproductive
capacity. Specific Aim 2 is to provide state-of-the-art services that allow valuable animal models to be banked
and recovered as needed to preserve these animal models or reduce the costs associated with maintaining
live breeding stock for novel models that are not actively being studied. GEAM staff are highly experienced and
capable of cryopreserving mouse and rat embryos or sperm and recovering mouse and rat models through
embryo transfer or in vitro fertilization. In addition, we are capable of rederiving mouse and rat strains to
eliminate pathogens that may compromise research or prevent animal models from being imported into our
vivaria or shared between investigators working at different institutions. Since its inception, GEAM has
generated hundreds of transgenic, knockout, and genome-edited mouse and rat models for UWCCC
members. Sixty-one unique UWCCC members have been served during the current CCSG funding cycle, an
increase of 30% compared to the previous grant cycle. Support from the CCSG allows our services to be
provided to UWCCC members at costs far below those of commercial vendors or similar cores at other
research universities. Convenient access to our first rate, cost-effective services enhances the ability of
UWCCC investigators to conduct innovative research that advances the UWCCC strategic mission.